Determinants of amino acid transporter oligomerization in membranes

ABSTRACT
The Amino Acid-Polyamine-organoCation (APC) superfamily of membrane transport proteins is one of the
largest families of solute carriers. They are involved in nutrient and amino acid transport across all kingdoms of
life. In humans, they are essential for amino acid transport in kidneys, neurotransmitter re-uptake in synapses,
movement of substances across the blood-brain barrier, and many other physiological roles. While their functions
are diverse, they adopt a common topological arrangement known as the "LeuT-fold", involving an inverted
topology repeat of 5 + 5 transmembrane helices, with an additional 2+ helices at the C-terminus that engage in
oligomerization in some isoforms. In recent years, structures of many LeuT-fold homologues have been solved
and in nearly every state along the transport cycle. When examining these structures, a major question stands
out - why are LeuT-fold transporters observed in diverse oligomeric forms (i.e. monomers, dimers and trimers)
despite possessing the same subunit fold? We hypothesize that oligomerization plays a role in APC transporter
regulation, and that all LeuT-fold transporters possess an innate potential to dimerize in membranes due to the
conserved subunit structure. However, the diversity of observed oligomers arises because of different stabilities
due to differences in protein and lipid contact surfaces. To investigate this, we will study a pair of APC
transporters that provide a model system for the rigorous investigation of this question. These are the
arginine/agmatine antiporter AdiC and glutamate/GABA antiporter GadC. These two transporters are
evolutionarily related within the same sub-family, and are both involved in extreme acid resistance in E. coli, yet,
AdiC has only ever been observed as a dimer, while GadC is monomeric. In addition, these proteins are easy
to purify and can be studied functionally in reconstituted systems, providing rigorous model systems to study
dimerization determinants of LeuT-fold amino-acid transporters. In this investigation, we will use a combination
of interdisciplinary studies that have allowed us to examine dimerization stability of other membrane protein
systems, such as the CLC Cl-/H+ antiporter and the dual-topology Fluc F- ion channel. Computational studies will
map out protein partners, interactions with water or lipids, and membrane structure in associated and dissociated
forms. Single-molecule photobleaching analysis experiments will be carried out to measure the equilibrium
dimerization affinity of subunits in membranes while testing key protein and lipid variables identified in the
computational analysis. In Aim 1, we will map out what defines AdiC dimerization, and in Aim 2, identify the
defining features that make GadC monomeric, with a final test to engineer GadC as a functional dimer. This
rigorous compare/contrast study between two model LeuT-fold transporters will provide a fundamental
understanding of oligomerization mechanisms relevant to all APC transporters, including those that are important
in human health and disease.

Public health relevance
NARRATIVE The proper assembly of membrane transport proteins in oligomeric states is of critical importance to cellular physiology, yet we often do not understand the molecular determinants of oligomerization or its impact on function. In this project, we will identify the determinants of dimerization stability of amino-acid transporters from the APC superfamily that adopt a LeuT-fold - AdiC and GadC. The research here will provide a fundamental basis for understanding of the assembly of human LeuT-fold homologues in neurophysiology such as neurotransmitter re-uptake (e.g. SERT, DAT) and substance transport across the blood-brain barrier (e.g. LAT1).